Functional genomic analysis of the CD8 T cell response to HIV vaccines in

DESCRIPTION (provided by applicant): The development of an effective HIV vaccine is one of the greatest global health challenges. However despite decades of research, no vaccine has yet been able to elicit protective immunity to HIV. Recently, efforts to develop vaccines against HIV have focused on optimizing the T cell response to vaccination because of the association between T cell immunity and viral control in HIV. However, the molecular correlates of an optimal CD8 T cell response to vaccination remain unclear. This investigation will identify the molecular characteristics of optimal CD8 T cell function after vaccination, using functional genomics, cellular immunology and animal models. In Aim 1, we will generate genome-wide expression profiles of tetramer-sorted HIV-specific CD8 T cells elicited by three HIV vaccines in current clinical development. We will compare these HIV-specific CD8 profiles to antigen-specific CD8 T cells responding to vaccines against vaccinia virus (VV) - one of the most successful vaccines ever developed. We will identify patterns of genes that are unique to each type of vaccine and signatures that are common to those vaccines, such VV, that induce highly functional CD8 T cells. Candidate mechanisms that confer different functional attributes to each vaccine-induced CD8 T cell response will be identified using detailed computational analyses. This will be the first comprehensive transcriptional analysis of vaccine-induced antigen-specific CD8 T cells, and will identify new molecular correlates of highly functional CD8 T cells. Increasing data suggest that adenovirus (Ad5) vectored vaccines elicit CD8 T cells with limited functionality. In Aim 2 we will test the hypothesis that genes upregulated in CD8 T cells responding to Ad5-vectored immunogens contribute to their sub-optimal function. Based on our studies in a mouse model, and supplemented with new data from Aim 1, we will evaluate the role of up to 96 candidate regulator genes that are increased in Ad5/HIV-induced CD8 T cells using functional genomic approaches. A series of highly parallel over-expression studies and RNAi-mediated knockdown experiments will validate the role of candidate genes as inhibitory molecules in human CD8 T cells and in a mouse model of Ad5 vaccination. The proposed studies will accelerate HIV vaccine development by discovering new correlates of optimal vaccine-induced T cell immunity, and identifying the mechanisms that govern CD8 T cell function after vaccination.

Public health relevance
PUBLIC HEALTH RELEVANCE: Despite decades of research, no vaccines have yet been able to generate an immune response that robustly protects against HIV, and we still don't know what type of immune response should be elicited by a protective vaccine. This proposal will use cutting-edge technologies to: 1) survey thousands of genes expressed by immune cells responding to HIV vaccines; 2) identify the patterns of genes that characterize the most functional vaccines; and 3) test which of these genes influences the function of the immune system. Information from this study will help identify new tests to evaluate how well vaccines work, and discover new ways to make a stronger immune response to HIV vaccines. PROJECT NARRATIVE Despite decades of research, no vaccines have yet been able to generate an immune response that robustly protects against HIV, and we still don't know what type of immune response should be elicited by a protective vaccine. This proposal will use cutting-edge technologies to: 1) survey thousands of genes expressed by immune cells responding to HIV vaccines; 2) identify the patterns of genes that characterize the most functional vaccines; and 3) test which of these genes influences the function of the immune system. Information from this study will help identify new tests to evaluate how well vaccines work, and discover new ways to make a stronger immune response to HIV vaccines. __SpecificAimsTextDelimiter__ 2) SPECIFIC AIMS Despite intensive study, we understand little about how effective vaccines stimulate protective immune responses, nor why ineffective vaccines fail to do so. Recently, efforts to develop vaccines against HIV have focused on optimizing the T cell response to vaccination because of the association between T cell immunity and viral control in HIV. The Step study evaluated the MRKAd5/HIV-1 gag/pol/nef vaccine, which generates high-frequency CD8+T cell responses to HIV. However, it failure to confer protective immunity to HIV infection. A major explanation for its failure may be that the functional properties of Ad5/HIV-induced CD8 T cells were not optimal. However, the molecular basis of the suboptimal T cell response elicited by Ad5/HIV is not known. In this proposal we will conduct genome-wide transcriptional profiling of tetramer+ HIV-specific T cells from recipients of three HIV vaccine regimens (MRKAd5/HIV, DNA/MVA and MVA/fowl-pox) to generate a comprehensive characterization of vaccine-induced CD8 T cells. These HIV-specific T cell profiles will be compared to antigen-specific CD8 T cells induced by vaccinia virus (VV). Because VV elicits highly functional CD8 responses, VV-specific CD8 T cells represent a 'gold-standard' against which to compare HIV-vaccine elicited T cells. In order to identify which genes regulate T cell function after vacination we will use comprehensive computational analyses of microarray data, followed by functional genomic experiments using RNAi and over-expression studies in human T cells and mouse models. Our goal is to identify and validate genes that regulate vaccine-induced CD8 T cell function. These novel genes could serve as biomarkers of CD8 T cell immunity after vaccination, and as therapeutic targets to improve T cell function. We have developed several experimental tools that uniquely position the investigators to attack this problem. We have developed methods to generate genome-wide expression profiles from very rare populations of tetramer-sorted antigen-specific CD8 T cells in human blood samples. This has allowed us to profile the HIV-specific CD8 T cell response in humans and identify critical regulator genes, such as the transcription factor BATF, that mediate T cell exhaustion. We have developed a mouse model of Ad5/GP33 vaccination that recapitulates the functional phenotype of Ad5/HIV-elicited T cells in humans. Finally we have assembled a unique collection of clinically annotated samples from subjects on HVTN vaccine trials. Aim 1: What are the molecular correlates of optimal T cell function after vaccination? Flow-cytometry analysis suggests that the functional quality of vaccine-elicited CD8 T cells varies greatly between vaccines. For instance, Ad5/HIV vaccination in humans and non-human primates generates a small minority of CD8 T cels that are polyfunctional. In contrast, highly successful vaccines like VV induce polyfunctional CD8 T cell responses. The molecular basis for this difference in function is not known. In this aim we will undertake genome-wide transcriptional profiling of antigen-specific CD8 T cells from recipients of three different HIV vaccine regimens, and compare them to T cell responses to VV vaccines. Analysis of T cells induced by these different vaccines will identify genes expression profiles unique to each vaccine type, and also gene signatures characteristic of the highly functional CD8 T cells elicited by VV. We will ask whether the expression profiles of T cels induced by pox-virus vectored HIV vaccines (DNA/MVA or MVA/Fowlpox) 'look' like the functional VV-induced CD8 T cells or instead resemble the sub-optimal Ad5/HIV-induced CD8 T cells. We will compare antigen-specific T cell responses to Ad5 vector antigens and HIV insert antigens in recipients of MRKAd5/HIV. Finally, we will use cross-species genomic comparison to identify conserved signatures of the CD8 T cell response to Ad5-vectored vaccines in humans and mice. This comprehensive transcriptional analysis of vaccine-induced CD8 T cell responses will permit the discovery of novel candidate biomarkers of optimal CD8 T cell function. Aim 2: Identify novel genes that modulate vaccine-induced CD8 T cell function. Our hypothesis is that genes upregulated in Ad5/HIV-induced CD8 T cells compared to highly functional VV- specific T cells impair T cell function. The development of genome-scale libraries of shRNA vectors and overexpression vectors now allows us to functionally assess large numbers of candidate genes implicated in the regulation of T cell function. Based on our studies in mouse model, and supplemented with new data from Aim 1, we will select a set of up to 96 candidate regulator genes increased in Ad5/HIV-induced CD8 T cells and use highly parallel overexpression studies and RNAi-mediated knockdown to validate their role as inhibitory molecules. We will systematically perturb each candidate gene: first in normal CD8 T cells; and then in HIV-specific CD8 T cells from MRKAd5/HIV vaccinees. Genes that impair T cell proliferation and cytokine secretion in vitro will be tested in the mouse model of Ad5/GP33 vaccination using transgenic and/or knockout mice to assess their role in the formation of CD8 memory to vaccination. These experiments wil provide a mechanistic basis for the suboptimal T cell function induced by Ad5/HIV vaccination.